INTEGRATIVE SYSTEMS BIOLOGY ANALYSIS OF CRITICAL ILLNESS AND INJURY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of the study is to create computer models of several types of critical illnesses and injuries. These include trauma, burns, life threatening infection and cardiac arrest.